Mechanical Control of Cell Proliferation and Branching Morphogenesis in the Embryonic Lung

PROJECT SUMMARY/ABSTRACT
In the embryonic lung, the bronchial tree is sculpted by a process known as branching morphogenesis. Defects
in branching can cause a variety of congenital malformations, such as pulmonary hypoplasia, which
compromises respiratory function due to decreased lung growth. Several of these defects are caused by
changes in the mechanical environment of the fetal lung, but it remains unclear how physical cues in the tissue
microenvironment direct the formation of the bronchial tree. Dynamic, quantitative studies of branching
morphogenesis are needed to unravel the regulatory role of mechanical forces during lung development. We
hypothesize that airway branching is driven by a mechanical feedback mechanism, in which patterns
of mechanical stress regulate the patterns of epithelial proliferation that sculpt the developing airways.
To test this hypothesis, we will use novel experimental platforms that allow us to control and quantify the
mechanical stresses within the embryonic airway epithelium. We recently developed a novel three-dimensional
(3D) traction force microscopy (TFM) assay for cultured embryonic organ explants, as well as a microﬂuidic
system to apply controlled ﬂuid pressures to intact embryonic mouse lungs. These techniques will be combined
with dynamic studies of cell proliferation and ﬁbroblast growth factor (FGF) signaling, as well as a novel
computational model of airway branching morphogenesis, to determine how physical cues regulate the growth
and remodeling of the embryonic lung. In Aim 1, we will determine how mechanical stress regulates patterns of
proliferation in isolated airway epithelial explants. Then, in Aim 2, we will use whole lung explant culture to
uncover how mechanical forces interact with FGFs to direct both normal and hypoplastic branching
phenotypes. Achieving these aims will help identify new therapeutic targets for diseases, such as congenital
diaphragmatic hernia, where airway branching morphogenesis and lung growth are severely impaired. These
results will also help guide pulmonary tissue engineers in their efforts to recapitulate aspects of embryonic
development in the laboratory to construct engineered lung tissue.

Public health relevance
PROJECT NARRATIVE Congenital lung disorders can cause serious health problems and often involve defects in airway branching. This research investigates how mechanical changes in the fetal lung contribute to the development of these disorders. This knowledge will be vital to developing new treatment strategies for the repair of injured or congenitally malformed pulmonary tissue.